PHASE II STUDY OF CHIMERIC ANTI-CD4 AND METHOTREXATE IN RHEUMATOID ARTHRITIS

To obtain data on safety and clinical dose response to chimeric CD4 antibody in patients with rheumatoid arthritis concomitantly treated with a stable regimen of low dose methotrexate.